Comprehensively mapping the functional and antigenic effects of mutations to the Lassa virus glycoprotein complex

Project Summary/Abstract
Lassa virus is estimated to cause thousands of human deaths each year, primarily due to spillovers from its
natural host, Mastomys rodents. Eﬀorts to create vaccines and antibody therapeutics must account for the
evolutionary variability of Lassa virus’s glycoprotein complex (GPC), which mediates viral entry into cells and
is the target of neutralizing antibodies. To map the evolutionary space accessible to GPC, I propose to use
pseudovirus deep mutational scanning to comprehensively map how amino-acid mutations to GPC aﬀect cell
entry and neutralization by monoclonal and polyclonal antibodies. Pseudovirus deep mutational scanning
involves creating large libraries of biosafety-level-2 single-round replicative pseudotyped lentiviruses carrying
all mutations to a protein of interest (i.e., Lassa GPC), applying a selection pressure, and then deep sequencing
the initial and selected libraries to quantify the eﬀects of each mutation.
Aim 1 of this proposal will characterize functional constraints throughout GPC as well as across Lassa
lineages by mapping the eﬀects of mutations on cell entry. The insight provided by this aim will aid the design
of immunogens for candidate vaccines and therapeutics.
Aim 2 of this proposal will quantify how mutations aﬀect antibody-based neutralization from both
monoclonal antibodies and polyclonal sera. Monoclonal antibodies are being developed as therapeutic
cocktails; therefore, prospectively identifying escape mutations can guide development of antibody-based
therapeutics against current Lassa diversity and possible future evolution. Furthermore, little is known about
the polyclonal humoral response to natural Lassa infections and candidate vaccines, so mapping GPC
mutations that escape neutralization from polyclonal sera will provide insights into the speciﬁcity and breadth
of antibody based immunity as well as the person-to-person variation of immune responses.
Aim 3 will leverage the comprehensive antibody escape measurements to assess how the natural
diversity aﬀects the neutralizing capability of potential antibody-based therapeutics. Analyzing the
antigenicity of the current natural Lassa virus strains will provide valuable insight for the development of
region-speciﬁc and pan-Lassa virus therapeutics. To facilitate the use of this data by other researchers, I will
integrate these maps into an interactive Lassa virus phylogenetic tree publicly available on Nextstrain.
Overall, this work will provide information vital for understanding the forces that drive GPC variation,
enabling the design of therapeutics robust to viral escape, and understanding the potential for future GPC
evolution.

Public health relevance
Project Narrative Lassa virus is the causative agent of Lassa fever and is estimated to cause thousands of human deaths every year as well as posing a potential pandemic risk. Eﬀorts to create vaccines and therapeutics have been complicated by the natural diversity of the virus, especially in the glycoprotein complex (GPC); therefore, this study will use pseudovirus deep mutational scanning to comprehensively map how amino-acid mutations to GPC aﬀect cell entry and neutralization by monoclonal and polyclonal antibodies. Mapping the eﬀects of GPC mutations will provide information vital for understanding the forces that drive GPC variation, enabling the design of therapeutics robust to viral escape, and understanding the potential for future GPC evolution.